APOL1 and increased risk of Preeclampsia in West Africa

PROJECT SUMMARY
Despite the remarkable overall progress in reducing maternal mortality worldwide, preeclampsia continues to
be a major cause of maternal death, infant prematurity, and low birth weight in Africa. Preeclampsia is
especially high in Ghana occurring in 7.9% of term pregnancies. Preeclampsia presents during mid-
pregnancy with hypertension and proteinuria, and frequently includes kidney, liver, hematological, and
neurological dysfunction, as well as reduced fetal growth. Kidney disease is strongly linked to preeclampsia
and may have a causative impact through abnormal vascular responses to placentation and endothelial
dysfunction. A genetic predisposition to preeclampsia has long been suspected, but is essentially unstudied
in Africa. As a candidate gene for preeclampsia association, apolipoprotein L1 (APOL1) is a known risk factor
for end-stage and chronic kidney disease. APOL1 high-risk variants are present at very high frequency in the
same West African populations that also show high levels of preeclampsia. The proposed research will (1)
determine maternal and infant APOL1 risk variants and their association with preeclampsia, (2) provide novel
insights into genetic factors that impact maternal risk and perinatal outcomes, and (3) create a West African
preeclampsia genetics research infrastructure, based on a characterized patient cohort (700 cases and 700
controls) and a bio-specimen repository. The project will determine the association of APOL1 variants in
mothers and infants, with preeclampsia frequency and neonatal health. The expression of APOL1 mRNA,
stratified by APOL1 variant status, will be examined in placentas, in the preeclampsia patients/control
population. Finally, the incidence of kidney disease, APOL1 variation, hypertension, and preeclampsia will be
examined in the clinical population. The proposed training and research will be performed in Accra, Ghana,
at the Korle Bu Teaching Hospital, School of Medicine and Dentistry, College of Health Sciences, University
of Ghana, and the Noguchi Memorial Institute of Medical Research. The trainee, Dr. Charlotte Osafo
(MBChB), will be supervised by a mentoring team of senior physicians and scientists in Ghana, the United
States, and Canada. The mentoring team has extensive research expertise in maternal health, hypertension,
chronic kidney disease, clinical studies research, and human genetics. The overall research objective is to
uncover the interaction of population genetic variation with preeclampsia, and maternal and infant health
outcomes.

Public health relevance
PROJECT NARRATIVE Preeclampsia is a significant cause of maternal death and infant prematurity, particularly among West Africans and Americans of African descent. The ability to predict preeclampsia in expectant mothers, before obvious symptoms appear, may be possible using genetic tests. The proposed project will explore links between genetic variants and preeclampsia in West Africa and may result in novel predictive tests for this disease.